A dietary intervention clinical trial to reduce inflammation and improve outcomes in chronic pancreatitis

Project Summary
Chronic pancreatitis (CP) is a fibro-inflammatory syndrome of the pancreas that develops in individuals with
genetic, environmental, and/or other risk factors who develop persistent pathological responses to
parenchymal injury or stress. CP patients develop a number of metabolic and nutritional complications. To
date, no treatment is available to reduce or reverse the inflammatory damage associated with CP, and
management is limited to treating complications after they develop. Nutritional studies and strong
epidemiological data provide rationale for dietary interventions to reduce inflammation and improve clinical
outcomes in chronic diseases such as CP. Data from our group demonstrates a soy-enriched diet can reduce
pro-inflammatory cytokines and suppressive immune populations in prostate cancer patients, and soy
isoflavones can reduce immune cell activation in vitro. Carotenoids (lycopene) are suggested as the bioactive
agents responsible for the health benefits of tomatoes and directly modulate inflammation. Preliminary Data:
Our team has developed a novel soy-tomato juice for use in human studies, which has previously been
evaluated in healthy individuals for compliance, bioavailability, and effect on blood lipids. Preliminary data in
this proposal shows that administration of this soy-tomato juice to human participants (NCT03783013) is
tolerable, safe, and it is feasible to analyze immune populations in the blood. Additional work from our group
provides evidence this soy-tomato dietary intervention can reduce inflammation and the severity of CP in a pre-
clinical animal model. We observed that a soy-tomato diet in mice with CP reduces acinar destruction and
fibrosis, systemic inflammatory cytokines and immune populations, and improves physical activity levels.
Impact: This pilot trial will generate evidence to demonstrate the safety, compliance, and efficacy of a soy-
tomato juice to reduce inflammation, and ultimately improve clinical outcomes in participants with CP. Project
Hypothesis: A novel soy-tomato dietary intervention will reduce inflammation and improve outcomes in
individuals with CP. The goals of this small R01 pilot trial project are to: 1) conduct a pilot clinical trial to assess
the safety and compliance of our soy-tomato dietary intervention in participants with CP, and 2) evaluate the
effects of the diet on inflammation and patient-reported outcomes (PROs). We propose the following aims:
Aim 1. Conduct a pilot clinical trial to demonstrate the tolerability and compliance of a soy-tomato dietary
intervention in CP. Aim 2. Demonstrate the efficacy of a soy-tomato dietary intervention to reduce systemic
inflammation in CP and assess preliminary data regarding improvement in patient reported outcomes. After
completion of this small R01 clinical trial project, we believe the data will inform a larger clinical trial to
investigate the efficacy of this soy-tomato dietary intervention to improve PROs in the CP patient population.

Public health relevance
PROJECT NARRATIVE Chronic pancreatitis is an inflammatory syndrome of the pancreas that has no pharmaceutical treatment options. Given preliminary epidemiological and pre-clinical data demonstrating the efficacy of nutritional interventions, we propose to test the ability of a novel soy-tomato juice to reduce inflammation and improve health via a clinical trial in subjects with chronic pancreatitis. Our trial, collection of inflammatory markers, and interrogation of correlatives to dietary components could provide novel nutritional recommendations to improve inflammatory status and clinically-relevant biomarkers in individuals with this syndrome.